Hippocampal Representation of Sequential Information

This project will examine how neuronal ensembles within the hippocampus, as well as associated parahippocampal cortical areas and prefrontal cortex, represent information in the service of episodic memory for non-spatial information. Our experiments are guided by the hypothesis that information about individual items and spatial context are separately represented in distinct parahippocampal areas, that area CAS encodes items in the context in which they were experienced, and that area CA1 encodes and retrieves the order in which the items were experienced;and our experiments are guided by Hasselmo's models of the mechanisms underlying this scheme. Multi-channel microelectrodes will be used to record the firing patterns of neurons in hippocampal, parahippocampal, and prefrontal areas in rats performing hippocampaldependent tasks that assess rats'ability to remember once-presented sequences of odors and to disambiguate overlapping odor sequences. In the sequence memory paradigm, we will characterize and localize sequence coding, spatial context coding, and coding of item familiarity within this brain system. In the sequence disambiguation paradigm, we will test the hypothesis that overlapping events in two sequences are represented distinctly for each sequence. In both paradigms, we will determine whether there are specific phases of the theta rhythm on which encoding and retrieval of sequence information occur, and whether sequential information from recent experiences persists during a memory delay. For all of these measures we will characterize the extent to which neural firing patterns predict memory performance. The design and focus of these studies is guided by observations of humans performing similar tasks and provides a cellular level analysis not possible in functional imaging studies on humans. These experiments proposed here will be compared with parallel studies on spatial sequence processing, seeking to identify common fundamental mechanisms of non-spatial and spatial sequence representation. The experiments are aimed to test models and to guide the further development of models of hippocampal circuitry that support the temporal organization of episodic memory.